SIGNALING INTERACTIONS OF B LYMPHOCYTE CD5

The CD5 molecule, a pan-T lymphocyte marker, is present on an uncommon subset of circulating B lymphocytes. In human beings, the subset of CD5+ B cells is the proliferative component in chronic lymphocytic leukemia and may be responsible for a variety of auto-immune diseases. Cattle infected with bovine leukemia virus, an oncornavirus which is structurally similar to HTLV-I, often develop persistent lymphocytosis, a non-neoplastic polyclonal expansion of CD5+ B cells. These animals offer a source of numerous CD5+ B cells for biochemical analysis, as well as being an animal model of a naturally occurring disease involving proliferation of this cellular subset. In T cells, the CD5 molecule is linked to known signal receptors and transducers and also binds to signal receptors on B cells. Despite these advances in understanding of the role of CD5 as a signalling molecule in T cells, its role in B cells is poorly elucidated. By analogy with T cells, it is likely that the CD5 molecule in B cells is important in both intra- and intercellular signalling. In this proposal, the goal is to characterize the interactions of the CD5 molecule in B cells from BLV-infected persistently lymphocytotic cattle. The specific aims are to: (1) Identify molecules which are physically linked to CD5 and determine if these molecules are protein kinases, (2) Identify molecules which act as ligands of B cell CD5, and (3) Identify and characterize domains of the CD5 molecule which interact with molecules identified in Aims 1 and 2.